Activity dependent mechanisms of human interneuron development

The proposed work aims to provide insights into the development of inhibitory neurons in the human brain using cutting-edge, human-derived stem cell models. By discovering the molecular mechanisms that guide the maturation of specific interneuron subtypes, this study could lead to new therapeutic strategies for treating neurodevelopmental and neurological disorders such as epilepsy and schizophrenia. Our findings will reveal molecular and cellular specific mechanisms necessary for enhancing the efficacy of cell-based therapies to repair overactive brain circuits, control seizures, and improve cognitive outcomes in patients.

Public health relevance
PROJECT NARRATIVE The research proposed here aims at a deeper understanding of how neural activity during development of the brain shapes circuitry determining adult behavior and sensory processing, paving the way for more focused research on potential therapeutic targets. This research is likely to be informative for understanding basic developmental processes of neural communication, as well as have applicability across neurodevelopmental and neurological diseases where sensory processing is disturbed with cell-type specificity. Training of the applicant will potentially lead to next generation molecular technologies that will dissect how neocortical cellular populations contribute to complex goal-behavior and sensation.